Cellular Determinants of HCMV infection

Human Cytomegalovirus (HCMV) causes substantial disease in immunosuppressed patients, including
hematological cancer patients and transplant recipients. Further, HCMV is a major cause of congenital
disability. Successful HCMV infection relies on the viral modulation of many cellular factors. To identify novel
cellular determinants of HCMV infection, we have performed targeted CRISPR screens of biochemical data
sets and identified JUNB as a cellular factor that can inhibit HCMV infection. JUNB is a stress-induced
transcription factor that regulates inflammation. Our data suggests that the HCMV UL26 protein binds JUNB,
thereby attenuating its anti-viral activity. We will identify the mechanisms through which JUNB can restrict
HCMV infection (Aim 1) and elucidate how JUNB induces the activation of inflammatory gene expression (Aim
2). Lastly, we will determine how UL26 modulates JUNB’s activity (Aim 3). Collectively, our proposed research
will explore how a key inhibitor of anti-viral responses, UL26, modulates the activity of an important regulator of
inflammation, JUNB. The mechanisms involved will further our understanding of important host-pathogen
interactions and could potentially pave the way for novel therapeutic interventions.

Public health relevance
Human Cytomegalovirus (HCMV) causes permanent neuronal damage in thousands of infants in the United States every year and is responsible for significant disease and death in individuals with weakened immune systems, including transplant recipients and some cancer patients. Our proposal focuses on understanding the mechanisms by which a viral protein, UL26, modulates the activity of JUNB, a cellular transcription factor. Our results suggest that in the absence of UL26, JUNB induces an anti-viral state to inhibit viral replication. Understanding the mechanisms through which these cellular proteins impact infection could pave the way for novel therapeutic strategies to combat viral pathogenesis.